Tissue and Molecular Pathology (TMP)

PROJECT SUMMARY/ABSTRACT (TISSUE AND MOLECULAR PATHOLOGY SHARED RESOURCE)
The principal purpose of the Tissue and Molecular Pathology Shared Resource (TMP-SR) remains the facilitation
of tissue-based research by Rogel Cancer Center (Rogel) members. This SR was established in 1989 and
approved by the NCI in 1991. TMP-SR has made major contributions to Rogel individual and multi-investigator
projects, thereby facilitating many discoveries and high impact publications. Key services include Tissue
Procurement Services (TPS), Histology/Immuno-histochemistry Services (HIS), a Frozen Tumor Bank (FTB), an
Anonymous Paraffin Bank (APB), Tissue Microarray Services (TMS), and Molecular Pathology Services.